Center for Pediatric Tumor Cell Atlas - Admin Supplement

PROJECT SUM-OMVAERRYALL
ChildChaonocdietsrhseecomnodsctommocnausoefcshilddheoaotdChasn.ceirncshiladrrheeinghly
distfirnotcmhtoisnaedulCtasu.smeesc,hanainstdmhserapaepuptriocaccahnenbsoeetxtrapforloamted
thsetuodfaydumlatlignaTnoicmipeastc.hbteurdoefpnediactarnicrceerqsutihrseepsecsitfuiodcfy
pediactarnicceWres.therperfooptrohesieendepcthharacteorftihzrsaetpeieocnificofspuebdtiaytpreisc
malignawnhciictehos,getahcecro,fuonortve5r0%ofalplediactarnicdceerathhisg:ghragdleio(mpaHGG),
higrhinsekurobl(aNsBta)on,mvdaerhyigrhiasckultyemphobBl-acspetrlielcculresuokre(mViHaR-AALlLl).
thrteuemtoyrpsehsaarceharactoeftryipsiticinacilrtleiysaplotnotsheerfaoplyl,boywtehedemergeonfce
resisatnardnecferadcitsoerWayeswei.mlalpmolecaunlcdaerllcuhlaanrgientsumcoerlls,
microenviarnotdnhimememnutsnyestuesmicnogmprehemnuslitvie-dimseinsgilaoenn-idacnsleiltlu
technoalsosgoiceiwsaittehwcdorittircaanlsiitniirotenissap:loannsedem,ergeonfrceesisdtiasne-tase
bothhigh-ptrriaonrsiiTttryieoantmsmo.ednatlwiitilinlecslsutdaendcahredmothmeorlaepcytu,alragreted
theraapnicdehsimearnitcirgeecnep(tCoArRT-c)etlhlercaappyt,utrhicenugtteidngogefcurrceanntcer
therTahpfeyi.nparlodwuiciltmlpagcltocbhailldchaonocrdeerseairntchfheollomwainnnge1r)T:umor
Atlaastelsa:wsieplsrlovaihdieguhsleyfrriepnudbllyai,vcaliylsaebalrec,hdaabtlaeboaftshemeost
comprehemnuslitvie-soimnicgcela,lenlaloyfstihtsehrmeoesltetchhailldchaonocdeMrosl.ecdualtwaairll
bericahnlnyotwaittaehcdcetsoasdditpiaotnhaolleovgailcuaacltliionanin,codaultcodmaetsaan,gdrant
accetsossourdcaetsaucthumiomragi2n)Cgo.mputamteitohnoaidlnasd:dittotihodenattah,ceritical
computattoioaolnspdailpeluisneiedntshpirsojweibcletlavailtaotbhlreeseacrocmhmunTihteys.e
inclmuedtehoadnspdipelfiopnrreoscesmsuilntgi-aonmidinscisdtautian,feroefcnacnecpehrylogeny,
inferoefcneclaeln-cdlone-sppaetchiwfmaieyctsh,ofdoisrnfecrerlilnc-grcoeslslatswaelalksl,database
algorfiottrhhmqesuereyx,ploraantvdiiosnualoifhziagtchiolomynpdlaext3a)A.ccetsobsiospecfiomrens
folulposwtudbiieoss:pecciomlelneiscntthepidrsojweibcletlbankaendmdadaevailtaotbhlbeeiomedical
reseacrocmhmunTihteysi.encltuidsesseucetivoinasfb,rloyzsepneciamnepdna,tideenrtixveendograft
(PDmXodelIsns)u.mmatrhype,ropopsreodjweiscletletkoaddraemsasjpourbhleiaclnteheidnpediatric
broaidmlpyatchetentrierseeacrocmhmunaintjdyu,mpsttaarrdgtiestcobvaesreoydnasophisticated
understoaftnhdkeienmygoleccuilracrtuhidatrtsipveediactarniccer.

Public health relevance
Project Narrative Project Narrative Childhood Cancer is the second most common causes of childhood deaths in almost any age group. Our in-depth characterization of three major pediatric cancers will lead to improved understanding of the diseases and have the potential to greatly change the outcomes landscape of pediatric oncology.